Core 10: Health Literacy Core

Project Summary: Health Literacy
The overarching goal of the Health Literacy (HL) Core of the Louisiana Clinical and Translational Science
Center (LA CaTS) is to infuse HL, and Social Determinants of Health (SDOH) into clinical research to improve
health outcomes and reduce disparities among Louisiana’s most vulnerable populations. During the previous
funding cycles, the Core was highly effective in embedding HL principles in clinical research projects both within
and outside LA CaTS institutions to increase patients’ ability to obtain, understand, and use health information
and services as well as participate in clinical trials. The HL Core has enabled collaboration between LA CaTS
investigators and Federally Qualified Health Centers, as well as faith-based and civic organizations, in order to
infuse HL principles in COVID-19 testing and vaccine outreach projects targeting vulnerable populations across
the state. We have expanded our regional and national collaborations to include COVID-19 related research with
the University of Texas at Houston CTSA. Specific aims for this next cycle are designed to expand our network
to more investigators within and outside LA CaTS institutions to include HL principles and SDOH in their clinical
research to improve health outcomes and reduce health disparities: Aim 1. Enhance and expand trust-building
relationships with historically excluded populations to understand their specific needs, barriers, and strategies to
reduce health disparities. Aim 2. Collaborate with investigators at LA CaTS institutions to improve vulnerable
patients’ understanding and use of new health technologies that improve management of chronic diseases,
medication adherence, preventive care and recruitment in clinical trials, particularly in rural areas. Aim 3.
Network within LA CaTS, with CTRs, CTSAs in our region and nationally, and with health agencies within the
state, to provide equitable recruitment to clinical trials for historically excluded populations (rural and inner-city
communities, diverse race/ethnicity, LGBTQ, formerly incarcerated individuals) to more fully address health
disparities, and SDOH to improve health outcomes. We will accomplish these aims by: 1) expanding HL training
to include literacy and culturally appropriate use of health technologies such as patient health education on digital
platforms, patient electronic portals and digital apps to increase ongoing engagement with vulnerable
populations; 2) advising investigators in developing and sustaining trust in relationships with vulnerable
populations and community clinics, and agencies to address health disparities and improve participation in
clinical trials and health outcomes; 3) continue to collaborate with investigators within LA CaTS to include
Hispanic, rural, and other disadvantaged populations. These aims are designed to include a wide net of
stakeholders to design and evaluate acceptable and feasible research strategies to improve access,
understanding, and use of health information and services to improve the health of vulnerable populations.